Leveraging an electronic medical record infrastructure to identify primary care patients eligible for genetic testing for hereditary cancer and evaluate novel cancer genetics service delivery models

SUPPLEMENT ABSTRACT
This application is being submitted in response to NOT-OD-22-026 as a proposed administrative supplement
to the University of Utah (Utah)/New York University (NYU) U01 entitled “Leveraging an electronic medical
record infrastructure to identify primary care patients eligible for genetic testing for hereditary cancer and
evaluate novel cancer genetics service delivery models” (U01 CA232826). The parent U01 is employing an
electronic health record (EHR)-based clinical decision support (CDS) infrastructure to: (i) identify unaffected
primary care patients in the Utah and NYU healthcare systems who qualify for cancer genetics services based
on current guidelines (Aim 1); and (ii) compare two models of cancer genetics services delivery for identified
patients in a randomized clinical trial (Aims 2 and 3). In the parent study, we have identified a cohort of 22,208
primary care patients in the two healthcare systems who are eligible for cancer genetic services, and we are
planning for sustainability of this project. However, our prior data has shown disparities by race, ethnicity, and
language preference in the pool identified by the current CDS algorithm compared to the underlying primary
care patient populations. We have found that at least one contributing factor is systematic disparities in
availability and comprehensiveness of cancer family history information available in the structured EHR fields
upon which the current algorithm is based. These disparities raise critical ethical issues related to bias resulting
from integration of the CDS algorithm. We therefore propose to: (Supplemental Aim 1) Investigate whether
incorporating natural language processing (NLP) tools into the CDS algorithm reduces disparities in
identification of eligible primary care patients. We have created an NLP-augmented algorithm that incorporates
free-text comments and identifies 54% more patients than the current CDS algorithm. We will examine whether
use of the NLP-augmented algorithm impacts disparities in identification by race, ethnicity, language
preference, and rural/frontier residence compared with the underlying patient population. (Supplemental Aim 2)
Identify patients who nearly meet criteria for cancer genetic evaluation and explore acceptability of outreach to
those patients from medically underserved communities. We will develop a statistical model that can identify
patients who nearly meet criteria for cancer genetic evaluation, which would allow us to target outreach to
collect additional family history information. We will also conduct two community engagement studios, one in
English and one in Spanish, to examine the acceptability of direct outreach after identification by an algorithm
among individuals from medically underserved communities. Together these supplemental aims will investigate
two potential approaches to address observed disparities in patient identification. These findings will directly
inform the development of policies that explicitly include monitoring the impact of CDS algorithms and AI tools
on patient outcomes and disparities in those outcomes during iterative phases of testing and implementation.

Public health relevance
PROJECT NARRATIVE Identifying individuals with inherited cancer susceptibility is critical for targeted cancer prevention, screening, and treatment, and strategies to assess the genetic risk of unaffected individuals before cancer occurs are needed. This study will employ an implementation science framework to test a replicable electronic health record-based clinical decision support infrastructure to automatically identify unaffected patients from 48 primary care clinics in two healthcare systems, University of Utah and New York University, who qualify for cancer genetic services (Aim 1); and, using a randomized trial design with clinic-level randomization, compare the effects of two models of cancer genetic services delivery on uptake of genetic testing (Aim 2) and adherence to management recommendations after 12 months (Aim 3) among 1,920 primary care patients.